Molecular Mechanisms of Prion Disease with Translation to Novel Therapeutics

PROJECT SUMMARY/ABSTRACT I am a young neuroscientist with Ph.D. training from the University of Washington and postdoctoral training from the University of California, San Francisco. I have acquired solid knowledge in the principles of neuroscience and excellent technical expertise on neuronal signaling pathways and pharmacology in prion disease. My long-term career goals are to establish a research laboratory focusing on understanding and developing therapeutics against prion and Alzheimer's diseases as an independent investigator. In addition, I expect to teach and train health professionals and neuroscientists. To attain these goals, I intend to dedicate the 5 years award period to expand my scientific knowledge and expertise on research skills. The scientific activities of this proposal will include participating in seminars, journal clubs, national and international scientific meetings, preparing manuscripts for publications, and lab management. The research activities will include learning neuropathological analysis of prion and Alzheimer's diseases. Also, during the award period, I will learn techniques of immunohistochemistry and imaging, and get more hands-on experience on the convection enhanced delivery of gene products to the mouse brain for gene therapy against prion disease. Prion disease is one of the most devastating neurodegenerative diseases. Unlike other neurodegenerative diseases, it is caused by a single pathogen, pathogenic prion (PrPSc), which is converted from normal cellular prion (PrPC). However, physiological roles of PrPC and signaling pathways involved in prion disease are poorly understood. Identification of key molecules and pathways in prion disease will facilitate to develop early diagnosis and therapeutics targeting prion disease. Recent studies from our laboratory and others show that PrPC may play a role in amyloid precursor protein (APP) pathways. In this proposal, I will utilize a brain aggregate culture system, which represents the in vivo system most effectively. The benefits of using brain aggregates are reducing animal numbers for experiments, reducing numbers of days for experiments, and utilizing various aggregate cultures from transgenic mice. This project seeks i) to determine pathways or factors important in prion disease and ii) to develop therapeutics against prion disease using the multi- therapeutic approaches, based on its mechanisms. Elucidating pathways involved in prion disease may allow us not only to develop therapeutics, but also to identify factors for early diagnosis. As a long term goal, we hope to i) link pathological processes within neurodegenerative diseases, ii) shed light on the cellular processes that may be applicable to other neurodegenerative disorders and iii) develop therapeutics for neurodegenerative disorders.

Public health relevance
PROJECT NARRATIVE This grant will undertake a series of experiments in cell cultures and in mice to elucidate pathways in prion disease and to develop therapeutics against prion disease by a multi-therapeutic approach. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Prion disease is one of the most devastating neurodegenerative diseases. Unlike other neurodegenerative diseases, it is caused by a single pathogen (PrPSc), which is converted from the normal cellular prion protein (PrPC). The physiological roles of PrPC and signaling pathways involved in prion disease are poorly understood. Identification of key molecules and pathways in prion disease will facilitate the development of early diagnosis and therapeutics targeting prion disease. Most therapeutic studies using a single drug or a single gene therapy have not been successful to treat prion disease. Most survival extension is only about 10-25%. The overarching hypothesis for this proposal is that a multi-directional therapy is required to treat such a complex neurodegenerative disease like prion disease. In order to target multiple prion disease pathways, I will examine two signaling pathways which may play an important role in prion disease: i) ss amyloid precursor protein (ssAPP) pathways involved in regulation of PrPC expression and ii) Cdk5 pathways involved in modulation of cell survival and neuronal apoptosis upon prion infection. I will target multiple pathways affected in prion disease to develop treatment for prion disease. This study will also help to better understand molecular mechanisms of prion disease. Aim 1. To investigate modulation of ssAPP and Cdk5 pathways in prion disease. Studies showed that PrPC inhibits ss-secretase (BACE1) and that activation of the ssAPP pathway increases amyloid intracellular domain (AICD) and p53 leading to up-regulation of PrPC expression. My preliminary data also shows that i) the level of PrPC modulates BACE1 activities, which possibly regulate expression of PrPC as a negative feedback mechanism through AICD and p53 and ii) PrPSc infection reduces the level of PrPC. Also, my preliminary study showed that PrPSc infection changed the Cdk5/p35/p25 complex ratio, which is important for Cdk5 activity. I hypothesize that PrPSc infection modulates ssAPP pathways to induce PrPC expression and changes the Cdk5/p35/p25 complex ratio to induce signaling pathways towards neuronal death. It is interesting that Cdk5 plays a role in neuronal survival and death, including in Alzheimer's disease (AD). I will specifically examine the following two objectives: a. To determine whether ssAPP pathways modulates PrPC expression upon PrPSc infection b. To determine whether Cdk5 pathways are modulated in a course of prion disease Understanding pathogenic mechanisms of prion disease will suggest new targets for therapeutic purpose. Aim 2. To develop combination therapies for prion disease. The formation of pathogenic PrPSc requires PrPC. When the Prnp gene expression is ablated, mice are resistant to prion disease. Suppressing PrPC expression by gene silencing is potentially the best therapy for prion disease. However, a single gene therapy using a lentiviral vector linked with a short hairpin shRNA targeting the Prnp gene (PrP-shRNA) extended the survival of prion-infected mice only by 10-20 %. I hypothesize that multi-therapeutic approaches are required to treat prion disease. My preliminary studies showed that the intrathalamic infusion of an adeno- associated vector type 2 linked with enhanced green fluorescent protein (AAV2-eGFP) transduced most neurons in the thalamus but only axons or dendrites in the cortex. However, effective gene therapy for prion disease must be delivered to all neurons throughout the brain. The intrathalamic infusion of AAV2-PrP-shRNA transduced neurons and completely suppressed PrPSc formation only in the thalamus. Recent data from Dr. Bankiewicz's lab showed that AAV6-eGFP transduced most neurons in all regions of the brain. In my in vitro drug screening experiments, multi-drug treatments have more potential to treat prion disease in vivo. I will combine a multi-drug therapy with gene therapy using AAV6 to treat prion disease. a. In vitro screening of drug combination b. Pharmacokinetic profiling and toxicity study of multi-drug treatments in vivo c. Combination therapy of pharmaco- and gene therapies for prion disease The results of proposed studies in Aim 1 will not only advance our understanding of the mechanisms of prion biology and pathology, but also provide potential target pathways for prion disease. Furthermore, these results will provide more insights on overlapping pathways between prion disease and AD. The multi- therapeutic approaches proposed in Aim 2 will help develop more effective therapeutics against other neurodegenerative diseases. The long-term goal of this study is to provide a novel direction to develop therapeutics for CNS neurodegenerative disorders.